Lifestyle and Alzheimer's Disease In Down Syndrome

Project Summary
This application is being submitted in response to NIH's INCLUDE (OT-OD-20-025) Notice of Special Interest.
The purposed R01 provides the first longitudinal investigation of the time-ordered effect of four lifestyle factors
- physical activity, sleep, cognitive stimulation, and social engagement - on early Alzheimer's disease (AD)
neuropathology and the transition to clinical AD in adults with Down syndrome (DS). These lifestyle factors will
be assessed at a total of three time points, each spaced 16 months apart, in 140 adults with DS enrolled in the
NIH-funded Alzheimer's Biomarker Consortium in DS (ABC-DS; https://www.nia.nih.gov/ research/abc-ds).
Adults with DS are at genetic risk for AD due to the triplication of chromosome 21, which contains the gene for
the amyloid precursor protein and thus results in an overproduction of amyloid-bet (Aβ). Despite this genetic
risk, there is variability in the age of onset of clinical AD in the DS population. Lifestyle factors may contribute
to this variability, as has been found in non-DS populations including adults with early-onset familial forms of
AD. Indeed, as a group, adults with DS have been found to engage in a relatively high rate of sedentary
behavior, experience a high rate of sleep problems, and to have lifestyles marked by low levels of cognitive
stimulation and social engagement. In the proposed study, we will collect information on physical health, sleep,
cognitive stimulation, and social engagement across a 7-day/night period at three time points (spaced 16
months apart). Self/information report and objective measures (actigraph and WatchPAT) are used to assess
these lifestyle factors. This data collection will correspond in time with ABC-DS data collection of AD
biomarkers, cognitive functioning, and dementia symptoms and status. Time-ordered associations between
lifestyle factors and AD biomarkers (PET Aβ, PET tau, PET FDG, structural and functional MRI, and CSF Aβ
and tau, and blood) and cognitive functioning and dementia will be examined. The specific aims of the study
are to: 1) Examine the association between lifestyle factors –physical activity, sleep, cognitive stimulation, and
social engagement – and AD biomarkers longitudinally (T1 to T3; each spaced 16-months apart); 2) Determine
the association between lifestyle factors and cognitive functioning and dementia symptoms and status
longitudinally (T1 to T3); 3) Evaluate the moderating role of lifestyle factors on the relation between early AD
neuropathology (indexed by biomarkers) and cognitive functioning and dementia symptoms and status
longitudinally (T1 to T3). These lifestyle factors may be important modifiable resiliency mechanisms for
delaying clinical AD in adults with DS despite their genetic risk.

Public health relevance
Project Narrative Adults with Down syndrome experience an early age of onset and increased risk for Alzheimer's disease. The proposed study addresses this public health crisis and advances science by providing the first longitudinal investigation of the effect of four lifestyle factors (physical activity, sleep, cognitive stimulation, and social engagement) on the age of onset of early Alzheimer's neurodegeneration and on the timing of the transition to clinical dementia in adults with Down syndrome. These lifestyle factors may be important modifiable resiliency mechanisms for delaying Alzheimer's disease in adults with Down syndrome despite their genetic risk.